Research Training in Biobehavioral Disturbances of Eating Disorders

This is the first renewal application for a T32 grant, “Research Training in Biobehavioral
Disturbances of Eating Disorders.” The primary goal of this training program is to train
postdoctoral (MD, MD/PhD, and PhD) fellows for careers as independent researchers in
Eating Disorders. An intensive three-year program is outlined in which fellows learn how
to identify key research questions, formulate hypotheses, and design and execute
experiments that effectively test those hypotheses. In the course of training, fellows
acquire a range of skills relevant to research methodology, including expertise in
experimental design and statistical analysis relevant to clinical research. Graduating
fellows are able to present research projects clearly in both written and oral forms as
evidenced by publications and presentations. The training program outlined, utilizing the
outstanding faculty at Columbia University offers a unique opportunity to future
researchers in the field of eating disorders. The Columbia Eating Disorders Research
Unit has a long track record of recruiting and successfully training clinical researchers
with its success reflected in high rates of its trainees receiving K awards and pursuing
full-time academic careers. Also, the Columbia program has been highly successful at
recruiting MD researchers into the field of eating disorders, making it an unusual training
program in this specialized area. Prior to the start of this T32 program in 2013, research
fellows specializing in eating disorders at Columbia used other, more general research
training programs available in the department. As these programs became more focused
on basic science and neurobiology, they grew reluctant to accept candidates with
interests in the field of eating disorders whose interests may have been more clinically,
behaviorally, and translationally focused. The T32 program for eating disorders research
has gotten off to an excellent start, offering a comprehensive clinical research education
program, for outstanding candidates interested in eating disorders such as anorexia
nervosa, bulimia nervosa and binge eating disorder. The NIMH has identified eating
disorders as an understudied area in need of research initiatives. This application
outlines a training plan for future researchers in this important clinical area.

Public health relevance
This proposal, "Research Training in Biobehavioral Disturbances of Eating Disorders," requests support for a three-year research fellowship program for post doctoral MD and PhD scientists to train much needed future researchers specializing in eating disorders, Eating disorders are medically and psychiatrically serious illnesses in critical need of research into their underlying mechanisms and potential treatments, The training program outlined in this application describes a plan to successfully train clinical researchers in this specialized area,